Fibroblast dysregulation promotes dermal eosinophilic/Th2 inflammation

Abstract: Atopic dermatitis (AD) is one of the most common inflammatory skin diseases with an estimated
prevalence approaching 5% in adults and is typically characterized by pediatric onset, pruritis and persistance.
Research has indicated that AD is associated with an impaired epithelial barrier that promotes sensitization to
environmental antigens and a type II immune response. Despite advances in AD research, the causative
mechanism(s) leading to the persistent type II immune response remain unclear. Our recent publication and
Prel Data indicate that the dermis and subcutis contain fibroblasts that appear to be involved in establishing type
II inflammatory reactions in skin. Understanding how dysregulation of skin fibroblasts contributes to
downstream events that they may intitiate formation of inflammatory AD-like lesions is the focus of this
proposal.
Our Prel Data show that dysregulation of NF-kB signaling in Prx1+ fibroblasts leads to upregulation of CEBPb
in fibroblasts, upregulation of CCL11 and tissue eosinophilia followed by type II skin lesions resembling human
AD. Our mouse model shares many similarities with human AD-like lesions involving both the dermis and
epidermis at the histologic, cellular and molecular levels. Prel Data compares single cell RNAseq analysis from
our study with published scRNAseq databases from human AD lesions. scRNAseq analysis from our model and
human AD show fibroblast dysregulation involving CCL11 and CEBPb. Moreover, using RNAScope we have also
shown that validated human AD samples contain increased numbers of dermal fibroblasts co-expressing CEBPb
and CCL11 compared to matched control human skin, also consistent with our murine model. Thus, we propose
novel preclinical and translational studies (Aim 1) to define molecular mechanisms by which fibroblast
dysregulation mediated by CEBPb induces an inflammatory phenotype in these cells. Aim 2 will determine the
role of eosinophil infiltration as a key intermediate for triggering type II immune response in AD-like skin. Aim
3 will use spatial transcriptomics (GeoMX) and RNA seq to explore equivalent mechanisms in human fibroblasts
and AD specimens and translational studies using inhibitors as potential treatments for AD. We expect the
proposed studies along with recent reports in the literature to contribute to a paradigm shift in understanding
AD pathogenesis regarding fibroblast dysregulation and contribute to development of new therapeutic
interventions that may prevent the development of AD.

Public health relevance
Narrative: Atopic dermatitis (AD) is one of the most common inflammatory skin diseases in humans. Although the disease has been studied for decades, we still do not have a clear understanding of the mechanisms regulating the development of cutaneous AD. In this proposal, we will characterize a novel biological mechanism that involves fibroblast dysregulation in the formation of AD-like lesions in mice, examine similar events in human AD specimens and test potential therapies.